Mechanisms of salivary epithelium-specific expansion post-irradiation

Project Summary
Intact salivary glands facilitate several fundamental human needs, including breathing, swallowing, and lingual
communication. However, salivary glands are extremely sensitive to irradiation (IR), and their critical functions
are often irreversibly compromised following cancer radiation therapies. Previous attempts have identified
mechanisms that could prevent IR damage and/or regenerate salivary epithelium in murine models. However,
many of these pathways also promote cancer growth post-IR, significantly limiting their selectivity. Therefore,
identifying mechanisms that can specifically protect or regenerate salivary glands without benefiting cancer
growth post-IR remains a crucial scientific challenge that lacks efficient models.
To solve this problem, we developed a scalable and rapid gene targeting system that can test over 2,600
genetic conditions in the salivary glands of a single mouse, significantly improving the efficiency of the current
“one mouse one condition” paradigm of genetic modeling. Using this robust platform and a TetOn-shRNA pool,
we tested 255 potential regulators of salivary epithelium growth for their ability to promote clonal expansion in
salivary glands and syngeneic OSCC grafts post-IR. Contrasting these two sets of screens led to the
identification of Smarca2 depletion as the top promoter of salivary gland-specific expansion post-IR without
supporting cancer growth, standing out from the majority of hits shared by both tissues.
In long-term observation, we found that Smarca2 depletion specifically promoted salivary epithelium growth by
expanding the acinar population, which is particularly hard to replenish post-IR and represents a key area the
field is trying to address. Pre-IR induction of shSmarca2 suggested that Smarca2 depletion did not prevent
salivary epithelium from DNA damage, apoptosis, or senescence. While post-IR induction of shSmarca2
showed that Smarca2 depletion robustly increased the dividing population and their division potential in acinar
cells during early-stage regeneration. Mechanistically, depleting Smarca2, a core component of the SWI/SNF
chromatin remodeler complex, resulted in the shutdown of key terminal differentiation genes enriched for
Smarca2 occupancy. Additionally, Smarca2 depletion drove robust indirect activation of regeneration genes,
potentially through retargeting SWI/SNF or other remodelers. Intriguingly, this program was uncoupled from
Smarca2 depletion in OSCC cells, potentially blocked by the cancer-specific epigenetic landscape. In the
current project we will explore the cellular strategies of Smarca2 depletion driven salivary epithelium expansion
and underlying chromatin remodeling mechanisms using both murine/human salivary gland and cancer models.
Our discovery of Smarca2 depletion-driven acinar cell expansion represents a salivary gland-specific
regeneration switch without promoting cancer growth. Accomplishing this project will establish a paradigm for
understanding the distinct post-IR growth control mechanisms between salivary epithelium and cancer at the
chromatin level, an area that is significantly underexplored.

Public health relevance
Project Narrative Identifying mechanisms that can specifically protect or regenerate salivary glands without benefiting cancer growth post irradiation (IR) remains a crucial scientific challenge that lacks efficient models. By developing a rapid and scalable gene targeting system in the murine salivary gland and performing highly stringent genetic screens in salivary epithelium and cancer cells, we identified depleting Smarca2, a core component of the SWI/SNF chromatin remodeling complex, as the top promoter of salivary epithelium-specific expansion post-IR without supporting cancer growth. By demonstrating the cellular and molecular mechanisms underlying Smarca2 depletion driven salivary epithelium expansion in both murine and human models, our project will establish a paradigm for understanding the distinct post-IR growth control mechanisms between salivary epithelium and cancer at the chromatin level, an area that is significantly underexplored.